OCTREOTIDE EFFECT ON SODIUM BALANCE/SYSTEMIC HEMODYNAMICS IN CIRRHOSIS &ASCITES

The purpose of this study is to see the effect that Octreotide has on sodium balance and systemic hemodynamics in patients with cirrhosis and ascites. The study is designed as a double-blind, placebo controlled, cross-over study. Thus far, 9 patients have been randomized to therapy, 7 of who have completed the study and 2 are still pending. The study is continuing.